FIsetin to Reduce Senescence and mobility impairmenT in PAD: the FIRST Pilot Randomized Trial

FIsetin to Reduce Senescence and mobility impairmenT in PAD: the FIRST Pilot Randomized Trial
Lower extremity peripheral artery disease (PAD) is a major cause of disability in older people. In people
with PAD, lower extremity ischemia during walking activity is associated with reduced gastrocnemius (i.e. calf)
myofiber size and increased gastrocnemius fibrosis. These gastrocnemius muscle abnormalities are
associated with functional impairment and mobility loss in people with PAD. Yet few therapies improve
disability in people with PAD. We hypothesize that ischemia-induced senescent cell accumulation in the lower
extremities contributes to walking impairment in PAD and that fisetin, a flavonol and potent senolytic therapy
that destroys senescent cells, will improve lower extremity functioning in PAD, compared to placebo.
Senescent cells are metabolically active cells that have lost normal physiologic function. Approximately 30-
70% of senescent cells secrete inflammatory and pro-fibrotic cytokines and other molecules. These
inflammatory and pro-fibrotic cytokines and other molecules are called the senescence-associated secretory
phenotype (SASP). The SASP diffuses locally (paracrine effect) and circulates systemically, promoting
inflammation, stem/progenitor cell dysfunction, and fibrosis. Senescent cells resist apoptosis and immune
clearance, damage surrounding tissue, and accumulate at sites of tissue pathology. We hypothesize that
reducing senescent cells will improve walking performance and prevent disability in people with PAD.
Fisetin is a flavanol, present in strawberries, apples, and persimmons, that destroys senescent cells (i.e. a
senolytic therapy). Of three senolytic therapies identified in preclinical studies that are currently undergoing
evaluation in preliminary human clinical trials with our co-investigator Dr. Kirkland, fisetin has the best safety
profile. Hence, we propose a pilot randomized clinical trial to gather preliminary data to test the hypothesis that
fisetin will reduce abundance of senescent cells in blood, adipose tissue, and skeletal muscle, and improve 6-
minute walk distance in 34 people with PAD. Our primary aim is to assess whether fisetin, compared to
placebo, improves six-minute walk distance at 4-month follow-up in people with PAD. Secondary outcomes
include gastrocnemius perfusion, hand grip strength, the short physical performance battery (SPPB), and the
abundance of cells with senescent markers in blood, adipose tissue, and gastrocnemius muscle. Exploratory
outcomes include SASP measures in blood, gastrocnemius muscle, and adipose tissue. We will determine
whether greater declines in abundance of cells with senescent markers are associated with greater
improvement in 6-minute walk distance. If our hypotheses are correct, results will be used to design a definitive
randomized trial to determine whether fisetin, a widely available and well tolerated therapy, improves walking
ability and prevents mobility loss in the large and growing number of older people disabled by PAD.

Public health relevance
PROJECT NARRATIVE Patients with lower extremity peripheral artery disease (PAD) have greater functional impairment, faster functional decline, and higher rates of mobility loss compared to people without PAD. We propose a pilot randomized trial to gather preliminary data to test the hypothesis that fisetin, a flavonol present in strawberries and apples, reduces abundance of senescent cells in blood, fat, and skeletal muscle, thereby improving walking ability in people with PAD.